MOM2CHild Study: Leveraging systems biology toward discoveries in Maternal Obesity, Milk, and Translation To Child Health

PROJECT SUMMARY
Breastfeeding is recommended by the U.S. Public Health Service and American Academy of Pediatrics to
optimize infant nutrition and health. Breastfeeding initiation is approaching 85% of U.S. mothers, yet significant
gaps remain regarding our understanding of human milk and lactation as a biologic system. These gaps
undermine our ability to identify influences that may impair breastfeeding or reduce quality of milk. Obesity is
an ongoing public health epidemic that affects at least 29% of pregnant women and 19% of children and
adolescents. Maternal obesity influences not only pregnancy but also reduces breastfeeding duration and
exclusivity. In turn, reduced breastfeeding is associated with greater risk of childhood obesity in most studies,
though concerns about residual confounding undermine confidence in these findings. In addition, many small
studies have reported that maternal obesity is associated with shifts in milk components (notably, leptin,
inflammatory cytokines, fatty acids, oligosaccharides, and peptides) associated child adiposity or obesity. Many
of these shifts could be unhealthy and contribute to child adiposity by various means. To convincingly define
the impact of maternal obesity and its associated inflammation and co-morbidities on human milk, lactation and
child health, a systems approach is needed, drawing on the power of next generation technologies and large
cohorts. Here, we propose the MOM2CHild Study, which leverages systems biology towards discoveries in
maternal obesity, milk, and translation to child health. MOM2CHild will use data and samples from the
PREVAIL and IMPRINT birth cohorts, which are funded under cooperative agreements with CDC and NIAID,
respectively. These cohorts enroll Cincinnati mothers in pregnancy and follow children to >2 years. PREVAIL
has completed follow-up of 245 mother-infant pairs. IMPRINT will complete enrollment of 1,370 mother-infant
pairs by 2023. Both cohorts were designed and enacted by the same team, involve comprehensive
questionnaire and health databases and sample collection, including milk and other samples. Standardized
human milk collections from study mothers are undertaken at weeks 2 and 6. Neither cohort was originally
funded to extensively characterize human milk components, but samples have been carefully collected and
banked for that purpose. Under MOM2CHild, we will use the wealth of data and samples from PREVAIL and
IMPRINT cohorts, and apply metabolomics, fatty acid profiling, proteomics, glycomics, and microbiome
analysis, supported by state-of-the-art statistical and machine learning to: 1) Extensively characterize the
impact of maternal obesity, inflammation and metabolic dysregulation on milk composition using a systems
biology approach; 2) Identify the impact of maternal obesity, inflammation and metabolic dysregulation on
lactation success; and 3) Determine the impact of breastfeeding and variation in human milk composition on
child adiposity/obesity, inflammation, and metabolome to age 2. Our team is well-qualified in the scientific
domains needed to succeed in our aims, which align with the NICHD BEGIN initiative and RFA-HD-22-020.

Public health relevance
PROJECT NARRATIVE Using powerful technologies, we will comprehensively study the impact of maternal obesity and health on breastfeeding and the composition of human milk, and how they affect child growth and health. This project is enabled by using samples and data from ongoing birth cohorts including 1,615 Cincinnati mother-infant pairs.